Validated Immunoassays to Accelerate Therapeutic Genome Editing INDs

PROJECT SUMMARY / ABSTRACT
This application is submitted in response to RFA-RM-24-007 with the overriding objective of providing validated
assays to understand the immunology of gene editors in pre-clinical studies supporting investigational new
drugs (INDs) and eventually in clinical trials. Immunomonitoring is critically important to ensure safety as gene
editing therapies transition to the clinical setting for a wide range of applications and diseases. The goals of
these studies will be accomplished through the following Specific Aims: (1) Validate a cytokine flow cytometry
assay measuring T-cell immunity to commonly used gene editors, vectors, and related peptides from the
human peptidome; and (2) Provide a validated multiplex assay for binding antibodies against the domains of
relevant gene-editing proteins. We will validate these assays by demonstrating accuracy, precision, specificity,
linearity, and range with Quality Assurance monitoring. The assays proposed are based on cytokine flow
cytometry and the adaptation of a multiplex microbead immunoassay to accommodate multiple antigens of
interest for genome editors being tested for future human use. We will also track the implications of T-cell
responses to editors or self-proteins in vivo using total-body positron emission tomography (PET) to assist in
fully characterizing the assays proposed. These studies will accelerate the progress of safe and effective
somatic cell genome editing therapies to the clinic by providing rigorously validated assays for multiple editing
strategies. The assays are designed to address many Cas9-only editors, prime editors, and base editors—
while in addition providing a rigorous framework that can be adapted to future gene editors. FDA approved
PET imaging methods will also provide a powerful tool for accurately understanding in vivo events and best
practices for IND-enabling studies and clinical trials.

Public health relevance
PROJECT NARRATIVE The overarching goal is to optimize immunoassays focused on addressing the safety and efficiency of somatic cell genome editing in human clinical trials. These studies will provide validated methods and reliable tools for accurately assessing in vivo events and best practices to meet regulatory requirements focused on genome editing therapeutics.